Progenitor cell based therapy to mitigate radiation induced gastro intestinal syndrome

Project Summary:
Currently, there is a need for strategies that mitigate acute radiation-induced gastrointestinal syndrome (RIGS).
The risk of large populations encountering radiation exposure is real and growing. Although a few drugs are
available which can protect radiation injury if applied prior to radiation exposure, to date there are no agents
available which can be applied 24 hr post-exposure to mitigate the acute radiation syndrome. The high
radiosensitivity of the intestinal epithelium increases susceptibility to RIGS; and with mortality within 10-15 days
there is limited time for therapeutic intervention. We have developed a human peripheral blood mono nuclear
cell derived macrophage committed progenitor (MCP) cell therapy which can mitigate RIGS and improve survival
when applied 24 hr after an otherwise lethal dose of radiation exposure. These progenitor cells are modulated
ex-vivo to increase expression of WNT ligand, a major paracrine signal for intestinal epithelial regeneration. In
this project we will fully characterize this novel cell therapy with a determination of an optimum dose and schedule
for mitigation of RIGS. We will examine the general applicability of this strategy in young and radiosensitive
animals. Finally we will evaluate the involvement of MCP derived WNT signaling in repair and regeneration of
intestinal stem cells.

Public health relevance
Project Narrative: The proposed research will characterize a type of cell therapy as a countermeasure against radiation injury with efficacy at 24 hours after radiation exposure. This proposal will also define the mechanism of action of the countermeasure which will provide data necessary for product licensure requirements according to the FDA Animal Rule. Successful completion of this project will lead to the development of this cell therapy as a new medical countermeasure to treat injuries resulting from a radiation or nuclear accident.